Project 3: Chemokine modulation in TME for enhanced TLS formation and cross-priming/ recruitment of therapeutic CD8+ TILs

ABSTRACT
Chemokines (CK) play critical roles in the recruitment of immune cells into cancer tissues. Progressing tumors
are commonly characterized by local production of regulatory chemokines (CKs) and suppressor cells, while
production of pro-inflammatory CKs recruits protective CTLs and Th1 cells, dendritic cells (DC) and NK cells into
the tumor microenvironment (TME) in association with effective (immuno)therapeutic intervention. We have
recently shown that a combination vaccine targeting tumor vascular antigens (TVA) promotes specific CD8+ T
cell responses and the coordinate upregulation of stromal CCL5/CXCL9-11 production and therapeutic T cell
infiltration, and reduction in CCL22/CXCL12 production and MDSC/Treg content in the TME. Treatment also
promotes de novo production of CCR7-ligand CKs CCL19/CCL21 in the TME, and the development of tertiary
lymphoid-like structures (TLS). Remarkably, an autologous αDC1/TVA peptide-based vaccine administered with
dasatinib to immune checkpoint blockade (ICB)-refractory patients with advanced-stage melanoma
(NCT01876212) resulted in objective clinical benefit in 6 of 13 (46%) evaluable patients overall, including 4 of 7
(57%) patients exhibiting primary resistance to anti-PD1 blockade therapy. TCRBseq analyses revealed
increased TCR convergence (i.e. immune focus) in the therapy-induced TIL repertoire in advance of objective
clinical response. Furthermore, clinical responders exhibited unique TIL clonotypes post-treatment that were not
detectable in blood, supporting the TME as a relevant site for treatment-dependent T cell cross-priming and
“epitope spreading”. Since new preliminary data in murine B16 melanoma models suggests that therapeutic
efficacy of αDC1/TBVA-based vaccines is superior when combined with the Project 1-developed CK modulation
(CKM) regimen vs. dasatinib, Project 3, we will test the hypothesis that therapeutic benefits resulting from
αDC1/vascular peptide-based immunotherapy in immune checkpoint inhibitor (ICI)-refractory, advanced-stage
melanoma patients will be increased when combined with chemokine-modulating regimens (including CKM),
Specifically, we will perform a Phase I/II trial of Type-1-polarized dendritic cell (αDC1)/TVA peptide vaccination
in combination with tumor-selective chemokine modulation (CKM: Interferon-α2b, Rintatolimod and Celecoxib)
in advanced-stage HLA-A2+ melanoma patients with primary PD-1/PD-L1 resistance (Aim 1) and analyze the
on-treatment changes in TME and blood of patients to determine clinically-relevant changes in immunological
analytes (Aim 2). Animal modeling will then be performed to determine the role of vaccine format in the
therapeutic efficacy of combination CKM-based immunotherapy +/- immune regulatory antagonists (Aim 3).

Public health relevance
NARRATIVE In a recently completed pilot clinical trial administering a dendritic cell-based vaccine targeting tumor vascular antigens (αDC1/TBVA) + dasatinib, we observed a high rate of responses (4 of 7 patients; 57% ORR) in melanoma patients who had previously exhibited primary resistance to anti-PD1 checkpoint blockade and objective clinical benefit overall in 6 of 13 patients (46% DCR) on that trial. Treatment benefit was associated with changes in the balance of pro-inflammatory vs. regulatory chemokines and with immune infiltration (including the formation of tertiary lymphoid structures and evidence for T cell repertoire diversification) within patients’ tumors. These striking clinical data and our mouse studies showing much stronger therapeutic synergy between αDC1/TBVA and the chemokine-modulating regimen (CKM) developed within Project 1, compared to dasatinib, prompted us to perform a larger phase II study to evaluate the ability of αDC1/TBVA+CKM to induce objective clinical responses in patients with primary PD1-refractory, advanced-stage melanoma, identify the underlying mechanisms, and develop tools for prospective studies of survival benefit.